Hypoxia-induced aberrant lactate generation and shuttling serves as a direct signal to promote pro-fibrotic fibroblast phenotypes

Project Summary:
Relative hypoxia in the expanded alveolar interstitum in fibrotic lung disease can drive altered fibroblast
metabolism characterized by decreased mitochondrial respiration and increased lactate generation. Fibrotic
lung fibroblasts demonstrate aberrant phenotypes including persistent differentiation, increased matrix
production, apoptosis-resistance, and senescence, which are critical to the pathobiology of progressive fibrotic
lung disease. However, our understanding of the mechanistic links between hypoxia, lactate, fibroblast
phenotypes and lung fibrosis, is limited. Lungs from patients with IPF (a common and severe form of
progressive lung fibrosis) and from mice with experimental lung fibrosis have increased lactate levels. Inhibition
of lactate generation, either by preventing pyruvate formation from glucose or by blocking the conversion of
pyruvate to lactate, diminishes experimental lung fibrosis in murine models. But the mechanisms by which
lactate directly contributes to lung fibrosis remain unclear. We have shown that hypoxia differentially affects the
lactate production in normal and IPF fibroblasts through downregulation of the “B” isoform of lactate
dehydrogenase-B (LDHB, which decreases lactate by catalyzing conversion back to pyruvate) in IPF, but not
normal, fibroblasts. Combined with an increase in the LDHA isoform, this suppression of LDHB amplifies
lactate generation by IPF cells under hypoxic conditions. Our preliminary data now show that IPF fibroblasts in
hypoxic conditions also have an increase in the lactate export protein MCT4, which promotes lactate transfer to
the extracellular space. We have shown that lactate signals through its cognate receptor, GPR-81, to induce
normal fibroblast differentiation under hypoxic conditions. We now show that this direct effect of lactate is
mediated by a reduction in intracellular cAMP. Our in vivo data show that MCT4 and GPR-81 are increased in
the lungs of mice following bleomycin-induced lung injury. MCT4 and GPR-81 are strongly expressed in the
fibrotic interstitium and fibroblastic foci in IPF lungs, whereas LDHB is identified in normal, but not IPF lung
tissue. Finally, we show that GPR-81 inhibition can diminish bleomycin-induced lung fibrosis in mice. In this
proposal, we will examine 1) how hypoxia induces changes in LDHB, MCT4 and GPR-81 expression to
regulate lactate generation, shuttling, and signaling; 2) how lactate directly drives pro-fibrotic fibroblast
phenotypes (differentiation, proliferation, matrix synthesis, survival, mitochondrial function and senescence) via
GPR-81 dependent signaling in a hypoxic microenvironment, and 3) how systemic inhibition or mesenchymal-
cell specific deletion of MCT4 and GPR-81 (alone and in combination) impacts the resolution of lung injury and
fibrosis. These novel studies will enhance our understanding of how hypoxia-mediated aberrant lactate
production, shuttling and signaling directly contributes to lung fibrosis while interrogating the potential to target
lactate-mediated signaling as a therapeutic approach to fibrotic lung diseases including IPF.

Public health relevance
Narrative: Fibrotic lung diseases such as Idiopathic Pulmonary Fibrosis are increasing in prevalence in the United States and worldwide, yet there are no interventions that stop or reverse the formation of scar in the lungs. New approaches are needed to understand the fundamental mechanisms driving scar formation and to identify potential therapeutic targets. Our proposed studies will interrogate a novel role for lactate, generated under conditions of cellular oxygen deficiency, as a direct mediator driving the propagation of fibrotic disease and the effects of inhibiting lactate-mediated signals on lung fibrosis development and progression.